State-level factors and maternal and child health outcomes

PROJECT SUMMARY
This project uses cutting-edge legal epidemiology techniques to examine population-level maternal and child
health (MCH) impacts of pregnancy termination policies in the U.S., including identifying which groups
experience adverse consequences and the conditions that buffer consequences. Pregnancy termination in the
U.S. is common, with about one out of five pregnancies ending in a termination. Historically, most research
about public health impacts of pregnancy termination policies focused on the relationship between legal status
of pregnancy termination and maternal morbidity and mortality related to illegal versus legal pregnancy
termination. In the U.S. today, however, most pregnancy termination policies do not make all pregnancy
terminations illegal; rather, they create barriers to people being able to terminate their pregnancy. Most states
have at least one such policy and some states have had some pregnancy termination policies for more than 40
years. Recently, though, the number, strength, types, and co-occurrence of such policies have dramatically
changed; some of these policies and policy combinations have contributed to a decrease in the number of
pregnancy terminations. The next few years could bring even more drastic changes in these policies. Such
policy changes could have public health impacts on people who continue their pregnancies and give birth –
particularly on MCH outcomes such as maternal morbidity and mortality, infant mortality, and adverse birth
outcomes. Methodologically rigorous research about impacts of being unable to obtain a pregnancy
termination on subsequent MCH has been conducted at the individual-level. Yet, only very limited research,
much of it with notable methodological limitations, has been conducted at the population-level. This limits our
understanding of population-level impacts of pregnancy termination policies. In this project, we assess whether
state-level pregnancy termination policies from 2005-present affect MCH outcomes. We also examine whether
effects differ by race/ethnicity and socioeconomic status as well as by other state-level characteristics such as
economic, gender equality, and structural racism. This study involves state-of-the art coding of our exposure -
state-level pregnancy termination policies from 2005-present, including policy adoption and effective dates.
Outcomes include births and changes in composition of births, as well as MCH outcomes (maternal morbidity
and mortality, preterm birth, low birthweight, and infant mortality). Outcome data will come from insurance
claims data, vital statistics data, and the Pregnancy Risk Assessment Monitoring System. We will use both
epidemiologic and econometric data analysis approaches to allow for causal interpretation of findings. Findings
will provide key evidence to prepare public health and health care systems to care for groups of people most
affected by pregnancy termination policies, as well as identify other state-level policies and characteristics that
might help buffer any adverse MCH impacts of pregnancy termination policies.

Public health relevance
PROJECT NARRATIVE: State-level pregnancy termination policies have dramatically changed over the past decade. Only limited research examines the population-level maternal and child health impacts of such policies, and research to date has not identified subgroups most at risk of experiencing an adverse outcome or state-level conditions that might buffer such adverse effects. Understanding maternal and child health effects of these policies is crucial to prepare public health and health care systems to care for groups most affected by policies and to implement other strategies to buffer adverse impacts.